Development of dual inhibitors targeting the viral main protease and the host cathepsin L as SARS-CoV-2 antivirals

Project Summary
The severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), also called novel coronavirus 2019
(nCoV-19), started to circulate among humans around December 2019, and it is now widespread as a global
pandemic. There is no vaccine or antiviral available for SARS-CoV-2. In this grant, we propose to develop dual
inhibitors targeting viral main protease and cathepsin L as SARS-CoV-2 antivirals. Using the FRET-based
enzymatic assay, we recently identified several inhibitors including boceprevir, GC-376, and calpain inhibitors II
and XII, that have potent activity with single-digit to submicromolar IC50 values in the enzymatic assay.
Significantly, all four compounds inhibit infectious SARS-CoV-2 replication in cell culture with EC50 values
ranging from 0.5 to 3.4 µM. Overall, the compounds identified provide promising starting points for the further
development of SARS-CoV-2 therapeutics. Our discovery of calpain inhibitor II as a potent inhibitor against
SARS-CoV-2 is innovative as it suggests it might be feasible to develop SARS-CoV-2 antivirals by
simultaneously targeting both viral Mpro and host cathepsin L, both of which are essential for viral replication.
Compared to recently reported Mpro inhibitors, the hits identified from our study represent the most potent and
selective drug candidates with a novel mechanism of action, therefore warranting further development.
Given our encouraging preliminary data, we propose to optimize dual inhibitors as SARS-CoV-2 antivirals.
The objective of this proposal is to develop dual inhibitors as potent SARS-CoV-2 antivirals with high potency,
selectivity, favorable pharmacokinetic properties, as well as broad-spectrum antiviral activity against closely
related coronaviruses such as SARS and Middle East respiratory syndrome (MERS) coronaviruses.
Our goals of this grant are to identify additional dual inhibitors through both high-throughput screening and
structure-based lead optimization of our recently identified dual inhibitors. By targeting the SARS-CoV-2 Mpro,
the expected outcomes of the proposed research are broad-acting coronavirus antivirals with a confirmed
mechanism of action, a high selectivity index, and favorable in vitro pharmacokinetic properties that are ready
for in vivo antiviral efficacy testing in relevant animal models. Overall, this grant is based on strong preliminary
data and our expertise in developing antivirals targeting cysteine proteases.

Public health relevance
Project Narrative Severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) is a viral pathogen that leads to the COVID-19 pandemic. Currently there is no approved antiviral drug or vaccine for the respiratory diseases associated with SARS-CoV-2 infection. To address the unmet medical need, we will develop potent and selective SARS-CoV-2 inhibitors with high potency and selectivity, broad-spectrum antiviral activity, and favorable pharmacokinetic properties by targeting the viral main protease and the host cathepsin L, and provide lead candidates for the in vivo animal model studies.